Clinical Core

Clinical Core Abstract
Disease (AD) depends
: Progress in early risk detection, diagnosis, treatment, and prevention of Alzheimer’s
critically on the availability of large “trial-ready” cohorts of participants spanning a
spectrum from cognitively unimpaired to MCI-risk stages including subjective cognitive decline, mild cognitive
impairment (MCI), and early AD, and ultimately autopsy-confirmed AD and related dementias (ADRD). The PITT-
ADRC Clinical Core has effectively accomplished this with clinical evaluation and characterization of a cohort of
more than 5300 participants since 1985, enrolling over 430 new participants in this funding cycle thus far. The
Clinical Core is both a vital local research resource, providing participant referrals, biologic samples, diagnostic
expertise, and training for numerous federally funded grants to local investigators, and a leading contributor to
large scale national and international collaborative investigations including genetic and imaging biomarker
studies and large-scale prevention trials. In the current grant cycle, the Clinical Core implemented measures to
reduce barriers to recruitment and retention of economically disadvantaged participants; those residing in
neighborhoods with the most disadvantaged national quartiles of Area Deprivation Index (ADI) now account for
just over 50% of initial visits. ADI and other key metrics will be monitored monthly in a new dashboard to be
implemented in the next funding cycle to track recruitment goals in real time, including autopsy program
recruitment, to ensure diverse and equitable representation. In the current cycle, in collaboration with the NIC,
AT(N) neuroimaging biomarkers were systematically incorporated into the diagnostic consensus process. In the
next funding cycle, in collaboration with the Biomarker and Neurogenetics Core, ATX(N) blood biomarkers will
be similarly incorporated, to evaluate how these biomarkers might be practically utilized in clinical diagnosis and
biological staging. Other new initiatives in the renewal cycle include a pilot study evaluating remote digital
cognitive assessment platforms for future adoption; and new data collection of participant residential address
history, enabling linkage to a range of life-course regional exposome data, a significant expansion of structural
and social determinants of health measures. New initiatives will be implemented within the following set of
proposed Specific Aims: 1) To perform evaluations at study entry and at annual follow-up of participants in the
PITT-ADRC, across the spectrum of cognition from cognitively unimpaired (CU) through AD and related
dementias; 2) To assure maximum participation in clinical, intervention, brain imaging, biomarker, and autopsy
studies by providing appropriate research study referrals and clinical services during longitudinal follow up; 3)
To provide clinical data, research participants, blood and DNA samples, and scientific leadership to research
projects within and outside the University of Pittsburgh; 4) In collaboration with the ORE Core, facilitate
recruitment and retention of diverse participants; 5) To support the Research and Education Core (REC) in
training a diverse workforce as the next generation of dementia researchers and caregivers.